Continuous measurement and control of intraocular pressure in normal and glaucomatous eyes

PROJECT SUMMARY
Understanding the regulation of intraocular pressure (IOP) is crucial in diagnosing and managing glaucoma,
a leading cause of irreversible blindness characterized by preferential loss of retinal ganglion cell (RGC).
One of the most potent regulators is the autonomic nervous system, which most glaucoma medicines target
to achieve therapeutic IOP-lowering effects. Autonomic signals can modulate IOP rapidly by altering ocular
blood flow and slowly by adjusting aqueous humor production and outflow. As a result, IOP fluctuates over
a wide range of time scales. The importance of these fluctuations to glaucoma etiology and pathophysiology
remains largely uncertain.
Of interest to this project are circadian fluctuations in IOP that are controlled by the suprachiasmatic nucleus
(SCN) in the brain. IOP telemetry studies in rats and other animals find that these rhythmic fluctuations can
attain levels at night that would be glaucomatous if sustained throughout the day, and yet the eye continues
to stay healthy. How can this be? More research is needed on the influence of the circadian system and
environmental factors, such as light exposure, on the IOP dynamics of healthy and glaucomatous eyes. The
proposed work utilizes one-of-a-kind technologies for measuring and manipulating IOP round-the-clock in
awake free-moving animals as small as rats to investigate the hypothesis that daily IOP elevation is crucial
for eye function. So important that recurrent disruption of circadian signals to the eye at night by light, and
possibly other factors, pushes homeostatic mechanisms to raise IOP at unnatural times of day and that this
abnormal activation may contribute to glaucoma onset or accelerate disease progression. The specific aims
are to characterize light-driven changes in IOP rhythmicity and variability, the processes that mediate these
changes, and their impact on eye health in rats. Insights gained from the work could inform the development
of personalized treatment strategies or lighting regimens that optimize IOP control according to individual
circadian profiles and uncover novel pathways for glaucoma intervention and vision preservation to explore
in larger animals and humans.

Public health relevance
PROJECT NARRATIVE Glaucoma is an ocular disease that causes progressive and irreversible vision loss by damaging optic nerve fibers as they exit the eye. High eye pressure is a well-established risk factor for the disease, but it is not the only factor. This project uses one-of-a-kind technologies that we have created for monitoring and controlling pressure in conscious animals to investigate the impact of light on IOP rhythmicity and variability, elucidate physiological mechanisms of IOP rhythmicity and variability, and characterize IOP rhythmicity and variability in a rat model of ocular hypertension.